Racial Equity in Health Information Exchange and Emergency Care Quality for Adults with Alzheimer's Disease and Related Dementia

PROJECT SUMMARY/ABSTRACT
This K01 application is for Sunny C. Lin, PhD, MS, whose research focuses on improving the equity, efficiency,
and effectiveness of health information technology use for adults with Alzheimer’s disease and related
dementias (ADRD). Adults with ADRD account for over 40% of all emergency department (ED) visits among
patients over age 64, and are more likely to experience poorer quality ED care than those without. Adults with
ADRD who are racialized as Black may be especially at risk of experiencing poor quality care due to racial
prejudice, structural racism, and stereotyping. Among older populations, especially those with ADRD, access
to patient data is often critical to providing high quality ED care. However, obtaining reliable data from adults
with ADRD is often difficult or impossible. To fill this gap, many ED providers rely on health information
exchange (HIE) to access patient data. HIE can aid in diagnoses, reduce medication errors, and reduce time
spent in the ED. Moreover, studies have highlighted the potential for HIE to improve racial equity in ADRD care
by reducing physician bias in diagnostic and treatment decisions, increasing access to specialty care, and
identifying social needs. However, prior work has found that HIE efforts are often fragmented by upstream
determinants such as competition and resources, limiting data flows and potentially leading to racial inequities
in data access. There is a critical need for research on racial equity in HIE, especially among adults with
ADRD, a growing and vulnerable patient population. The aim of this proposal is to assess racial equity in HIE
connectivity and use and determine whether HIE is associated with better ED quality for adults with ADRD.
Utilizing two novel and complimentary datasets on adults with ADRD (i.e., Medicare claims and Electronic
Health Record event log data), Dr. Lin will 1) characterize racial disparities in ED quality, 2) identify patterns of
HIE use and its impact on ED process measures of quality, and 3) identify patterns of HIE connectivity and its
impact on ED outcome measures of quality. Dr. Lin’s career goal is to become an independent investigator
and nationally-recognized expert on equity in health information technology. Through this award, Dr. Lin will
achieve the following goals: 1) learn how social systems lead to and reinforce racial inequities in ADRD and
ED care, 2) become familiar with systems science techniques for understanding how racial inequities in
HIE data flows emerge, and 3) gain skills and experience in analyzing EHR event-log data. The proposed
research and training activities are made possible through the resources and expertise housed in Dr. Lin’s
home institution, Washington University in St. Louis, including: the Center for Advancing Health Services,
Policy & Economics Research, the Institute for Informatics, Data Science, and Biostatistics, and the Knight
Alzheimer’s Disease Research Center. Dr. Lin has the support of an exceptional mentorship team composed
of experts in health policy and equity, systems science and EHR event-log analysis, and ADRD and ED care.

Public health relevance
PROJECT NARRATIVE Access to health information exchange (HIE) is critical to ensuring that emergency care is maximally responsive to the unique needs of older adults with Alzheimer’s disease and related dementias (ADRD); however, prior research suggests that significant racial inequities in HIE may exist, exacerbating existing racial disparities in the care of older adults. The proposed study will 1) characterize racial inequities in emergency care quality, HIE connectivity, and HIE use, and 2) quantify the impact of HIE on ED care quality for adults with ADRD. This research is directly responsive to the National Institute on Aging’s 2020-2025 research goals to facilitate smoother care transitions for older adults, improve the interaction of older adults with the healthcare system, and understand and address drivers of health inequities and disparities related to aging and diseases such as ADRD.